Aspen Lung Conference Pulmonary Fibrosis - focusing on the future

PROJECT SUMMARY/ABSTRACT
With an emphasis on the integration of basic, translational and clinical approaches, the 66th annual Aspen Lung
Conference will focus on a central question: How can knowledge of cellular, molecular and genetic
mechanisms that underlie repair of fibrotic lungs help us to develop effective approaches to treat
pulmonary fibrosis? To address this central question, we have organized the program into a series of thematic
sessions, preceded by an opening keynote address to frame the conference. The thematic sessions will focus
on (i) the common threads of usual interstitial pneumonias (UIPs), (ii) exploring the dynamic cellular and
structural biology associated with lung fibrosis, (iii) diagnostic challenges and novel approaches to understand
and identify interstitial lung abnormalities (ILAs) and disease progression, and (iv) transformational interventions
for lung fibrosis as a pathway to develop precision therapies for the disease. By addressing these topics, we
seek to accomplish the following: 1) provide an international forum for leading basic, translational, and clinical
researchers to exchange ideas regarding the dynamic cellular and structural biology in lung fibrosis associated
with disease progression and repair; 2) stimulate interactions between scientific fields to identify emerging and
shared interests that may lead to more efficient and productive research; 3) enhance the likelihood of success
in translation of preclinical scientific advances into direct patient benefit by developing novel strategies to better
understand disease pathogenesis, resolution potential and to implement scientific advances in treatment of
pulmonary fibrosis; and 4) challenge and stimulate the scientific interests of trainees and attract a new generation
of early career investigators into the broad field of fibrosis, as well as underlying subdisciplines including
processes of repair of the epithelium, of matrix and the regenerative capacity of the lung. We have identified 11
outstanding thought leaders to present State of the Art lectures (35 min) on these topics. Each presentation will
be followed by 25 minutes of moderated discussion - a hallmark of the Conference. The program continues the
Aspen Lung Conference’s dedication to diversity and inclusivity: n=5/12 (42%) of State of the Art
speakers/Summarizer are women, and at least 5 of our speakers are from underrepresented racial/ethnic
groups. Participation of trainees and early career faculty is facilitated by two 15-minute oral abstracts, selected
from submitted abstracts, following each State of the Art speaker (24 total). There will be two evening poster
sessions for further presentation opportunities by trainees, early and level faculty (40 total posters). The final
presentation is provided by a Conference Summarizer, who reviews the impact and common themes of the
Conference. The Conference Summary will be published for widespread dissemination, to serve as a “think tank”
that not only summarizes the current state of the field, but also identifies key future directions for basic,
translation, and clinical research. Finally, and notably, registration for the Aspen Lung Conference is free,
encouraging participation from a wide spectrum of trainees and early career investigators.

Public health relevance
PUBLIC HEALTH RELEVANCE The prevalence of fibrosis is increasing due to the aging population, advances in diagnostic tools and increased exposure to infectious agents and other environmental factors that impact pathogenesis. Understanding the effect of these factors on the clinical manifestation of different fibrosis pathologies and pursing novel advances in lung regeneration after scarring will have a significant impact on lung health. By highlighting emerging concepts of shared relevance to the fields of lung biology and fibrosis and by addressing strategies to improve translation of scientific advances to reduce the burden of fibrosis and other lung diseases, the 2024 Thomas L. Petty Aspen Lung Conference will promote scientific advances in fibrosis biology, fibrosis resolution and therapeutic intervention, ultimately improving lung health.